Unsupervised Machine Learning to Identify Unique Clusters of Systemic Sclerosis Pulmonary Hypertension Patients

ABSTRACT
Unsupervised Machine Learning to Identify Novel Clusters of Systemic Sclerosis Pulmonary Hypertension
Patients
Pulmonary hypertension (PH) is a common devastating complication of systemic sclerosis (SSc), an
autoimmune condition characterized by fibrosis and inflammation of the skin and internal organs, particularly
the lungs and blood vessels. SSc patients can have PH related to numerous etiologies, most notably
pulmonary fibrosis/interstitial lung disease (ILD, termed group 3 PH) and/or a primary pulmonary vasculopathy
(pulmonary arterial hypertension [PAH], group 1 PH). Since SSc patients have varying degrees of ILD and
patients with ILD-PH and PAH can have identical pressures on right heart catheterization, it is challenging to
precisely classify individual patients using our existing scheme (i.e., group 1 vs group 3). This has important
implications for PH treatment choices and therefore further study is needed to improve our classification
system. The Pulmonary Vascular Disease Phenomics Program (PVDOMICS) is an NHLBI-funded project
aiming to deeply phenotype PH patients. The current project will be a secondary analysis of the PVDOMICS
dataset and the Johns Hopkins PH Registry to accomplish the following Specific Aims: Aim 1: Use
unsupervised machine learning to identify distinct clusters of SSc pre-capillary PH patients, incorporating
echocardiography, cardiac MRI, invasive cardiopulmonary exercise testing, clinical characteristics, and
biomarkers. Aim 2: Evaluate transplant-free survival and hospitalization rates in the newly identified clusters.
Principal component analysis and K-means clustering will be used to determine the novel clusters,
independent of our current classification scheme. Cox regression and receiver operating characteristics curve
analysis will be used to determine if the newly discovered clusters differ based on clinically relevant outcomes
and have improved discrimination and calibration compared to the traditional classification system. Successful
completion of these aims will establish novel methods for phenotyping SSc-PH patients that transcend our
current paradigm of group 1 vs group 3 classification. The potential clinical relevance of the cluster-based
classification method in patient-centered outcomes will be established. The long-term objective of this project is
to generate data to plan prospective phenotyping studies testing personalized treatment strategies based on
SSc-PH cluster assignment, which has the potential to change the paradigm of how we classify and treat this
complex subset of pulmonary hypertension patients.

Public health relevance
PROJECT NARRATIVE Pulmonary hypertension (PH) is a potentially fatal consequence of the autoimmune disease systemic sclerosis (SSc) and may be a result of a primary pulmonary vasculopathy and/or interstitial lung disease. The current classification system for SSc-PH is imprecise and may deny some patients appropriate treatment. In this proposal, we seek to investigate a new classification system by applying unsupervised machine learning to comprehensive cardiopulmonary testing from 2 datasets (PVDOMICS and the Johns Hopkins Pulmonary Hypertension Registry), which has the potential to improve outcomes for SSc-PH patients by tailoring treatments to more precise phenotypes.